Preventing GVHD by inhibition of alloantigen presentation in the gut

PROJECT SUMMARY/ABSTRACT
Blood cancers account for approximately 10% of all malignancies. In addition, non-malignant bone marrow failure
diseases such as aplastic anaemia, or immunodeficiency diseases such as severe combined immunodeficiency,
are life-threatening diseases and allogeneic bone marrow transplantation (BMT) is a preferred curative therapy
for these serious conditions. BMT outcomes are limited by transplant related complications, mainly graft-versus-
host disease (GVHD) and opportunistic infections. Indeed, 15-20% of BMT patients will develop severe GVHD
that is fatal, particularly when involving the GI tract. Current prevention and treatment of GVHD rely on the broad
suppression of T cells and remains suboptimal. The initiation and maintenance of T cell responses are dependent
on activities mediated by antigen-presenting cells (APC) but the types of APC that initiate GVHD and the factors
that promote their function is currently limited. This is the focus of this proposal. In particular, we will build on our
preliminary data to test the hypothesis that epithelial APC in the ileum initiate lethal Th1 dependent acute GVHD.
We will utilize cutting-edge mechanistic preclinical murine studies with parallel clinical analysis, using advanced
flow cytometry, single cell RNA/CITE-seq and ATAC-seq with new spatial protein and sequencing platforms to
focus on antigen presentation in the gastrointestinal tract, identifying clinically tractable pathways that will prevent
the development of lethal acute GVHD. This R01 renewal will continue to identify new, rapidly testing therapeutic
approaches to prevent GVHD based on the inhibition of disease initiation (i.e. alloantigen presentation) rather
than broad T cell suppression in the late effector phase of disease, as is current practice.

Public health relevance
PROJECT NARRATIVE Blood cancers account for approximately 10% of all malignancies and allogeneic bone marrow transplantation (BMT) is a major curative therapy, but is limited by transplant related complications, predominantly graft-versus- host disease (GVHD) that is often fatal. The proposal will study and define rapidly testable therapeutic approaches to prevent GVHD based on preventing the initiation of disease (i.e. alloantigen presentation) rather than broad suppression of T cells in the late effector phase of disease, as is current practice. In this manner we will define new strategies to prevent the side effects of transplantation, whilst permitting the development of robust immunity to pathogens.